Applying the Multiphase Optimization Strategy to Develop and Test a Culturally-Relevant Digital Health Intervention Targeting HPV Vaccination among U.S. Vietnamese

PROJECT SUMMARY/ABSTRACT
U.S. Vietnamese individuals (i.e., those living in the U.S. and identifying as Vietnamese) experience high rates
of HPV-related cancers. Despite the benefits of HPV vaccination to prevent HPV-related cancers, U.S.
Vietnamese adolescents have low HPV vaccine uptake (52% initiation and 35% completion). Digital health can
potentially be an effective approach to deliver culturally-relevant interventions targeting HPV vaccination among
U.S. Vietnamese, especially given the high rates of internet use in this population. Yet, few digital health
interventions on HPV vaccination exist for U.S. Vietnamese. More critically, existing digital health research on
HPV vaccination for Asian Americans and/or U.S. Vietnamese have typically employed the classic “treatment
package” approach where different intervention components are bundled into one package and the entire
package is tested in a trial. This approach fails to identify either the individual effect of each component or
whether the effect of one component is changed by the presence of other components. Understanding distinct
impacts of intervention components is critical for ensuring intervention efficiency, affordability, scalability, and
effectiveness. This study, HPV Education & Resources for the U.S. Vietnamese Population (HERO), will address
this critical gap. Dr. Ha Ngan (Milkie) Vu will leverage the Multiphase Optimization Strategy (MOST) framework
to conduct a pilot trial testing four different intervention components (expert video, self-persuasion, narrative
storytelling, and motivational interviewing) targeting HPV vaccination among U.S. Vietnamese. Additionally, she
will apply an implementation science framework to explore factors influencing the future implementation of the
intervention., represents the first systematic effort to assemble an optimal digital HPV vaccine intervention for
U.S. Vietnamese. The specific aims are to: (1): Assess the feasibility and acceptability of each of the four digital
HERO intervention components in a pilot trial; (2) Investigate effects of each component on HPV vaccination
outcomes and psychosocial mediators; and (3) Explore factors that may influence the future implementation of
HERO. This research is responsive to NCI’s priorities, including health equity, digital health, and reducing cancer
health disparities as well as to NIH’s efforts to enhance research on Asian Americans’ health. The proposed K01
research activities build on Dr. Vu’s formative research and are supported by robust community and clinic
partnerships. They also align with her career development plan, which includes training in (1) clinical trials design,
conduct, and evaluation; (2) digital health; (3) implementation science; and (4) professional development. Dr. Vu
has assembled a strong team of NIH-funded mentors and advisors with extensive experience in mentoring junior
investigators to independence. The K01 will be foundational to Dr. Vu’s career goal of becoming a leading
independent researcher who develops, implements, and tests culturally-relevant, evidence-based digital health
interventions to reduce cancer health disparities experienced by Asian Americans and underserved populations.

Public health relevance
PROJECT NARRATIVE U.S. Vietnamese individuals (i.e., those living in the U.S. and identifying as Vietnamese) experience high rates of HPV-related cancers and low HPV vaccine uptake. This K01 proposal applies the Multiphase Optimization Strategy to pilot-test culturally-relevant digital health intervention components to increase HPV vaccination among U.S. Vietnamese, while also using an implementation science framework to explore factors influencing future intervention implementation. Aligning with the NCI’s mission of promoting cancer health equity, this proposal also supports the career development of a junior investigator committed to developing and implementing interventions to reduce cancer health disparities among Asian Americans and underserved populations.